Administrative Core

Administrative Core - Abstract
The UNC Breast Cancer SPORE Administrative Core has supported the infrastructure, planning, and
evaluation of the UNC Breast SPORE since 1992. The Administrative Core and its co-leaders Drs. Perou,
Carey, and Earp are responsible for the institutional long-range plans and resource commitments of the
Cancer Center’s largest translational portfolio.
The functions of the Administrative Core include organizing weekly leadership meetings, monthly SPORE
faculty scientific meeting, quarterly Executive Committee and Advocate meetings, and the yearly External
Advisory Board. The Core collates formal reports to evaluate the progress of all SPORE elements, projects,
pilots and career development and mentorship. The Core facilitates interactions with the NCI SPORE program
and other NCI SPOREs, as well as with multiple breast cancer research collaborations both nationally and
internationally. The Core manages the Career Enhancement Program under Dr. Carey’s leadership, including
conducting external and internal searches for talented potential SPORE investigators. In these responsibilities,
she will be assisted by Marjory Charlot MD, MPH, UNC Lineberger Assistant Director of Community Outreach
and Engagement. The Core also manages the Developmental Research Program (DRP) with Dr. Earp as PI,
including organizing the pilot project competition and facilitating funding and evaluation of DRP projects. Dr.
Charlot will also be involved in these processes, particularly the new extension of the DRP, creating
opportunities for underrepresented in medicine (URIM) investigators. The Core follows all pertinent data
including trials and accrual. It manages the finances of the SPORE including the substantial institutional
commitment to CBCS, projects, infrastructure, recruitment, CAR T trial and breast cancer geriatric oncology
efforts. The total commitment will exceed $10M over the next 5 years. Through these activities, the
Administrative Core evaluates the finances, progress, and metrics in support of an exceptional team of breast
cancer translational researchers as they explore, address, and analyze disparities from multiple angles,
attempt to understand all facets and the potential of the immune system in therapy and resistance, use
genomic analysis to better understand prognosis and prediction, advance new technology, and develop junior
faculty into translational research leaders.